Crowdsourcing Labels and Explanations to Build More Robust, Explainable AI/ML Activity Models

PROJECT SUMMARY / ABSTRACT
As the population of individuals 65+ grows from 58 million to 88 million by 2050, so too will the number of
individuals who are aging with Alzheimer's disease and related dementias (ADRDs)1. The parent project
introduces clinically-driven technological methods to automate assessment of an older adult's functional health
from multimodal sensor data. What is lacking in the community, and in our parent project, is the availability of
ground-truth smartwatch activity labels. Without a sufficient amount of labeled data, machine learning models
cannot learn robust behavior models and use these models for functional health prediction. Additionally, the
categories of activities that have corresponding labels are very skewed, further limiting machine learning
performance because of the classical imbalanced class distribution problem. In this supplement request, we
propose to dramatically increase the availability of labeled smartwatch data for our parent project and for the
field. To do this, we will create a mechanism to crowdsource activity labels through Amazon Mechanical Turk.
Additionally, we will capitalize on the crowdsourcing opportunity to push the parent project to the next step by
laying a foundation for explainable machine learning models. Once our target number of activity labels is
reached, we will initiate a second round of crowdsourcing by asking citizen scientists to create one-sentence
explanations of the visualized data corresponding to an activity instance. The supplement project will contain
four tasks. First, we will create a visualization and data point-selection tool for use in the Amazon Mechanical
Turk (AMT) forum for data collection. A baseline active learning strategy will be used to collect an initial set of
labels and create a baseline model, after which, the active learning and annotator selection strategies will be
refined to collect the remainder of the activity labels. Finally, diverse data points from each modeled category
will be displayed to collect a set of text captions for training explanation models. The outcome of this supplement
project will be one of the largest sets of activity labeled smartwatch data collected “in the wild.” The labeled
datasets created by this supplement will offer a foundation for a multitude of health studies that can utilize
activity information observed by continuous wearable sensor readings collected in real-world studies. For the
parent project, the amount of labeled data will increase by over 10,000%. The supplement will also offer a
starting point for creating explainable mobile health AI/ML tools.

Public health relevance
PROJECT NARRATIVE In this supplement request, we propose to crowdsource activity labels and text captions for a large set of smartwatch activity sensor data using Amazon Mechanical Turk. The resulting labeled data will boost predictive performance for the parent project models and represent the largest publicly-available labeled set of data from smartwatch sensor readings collected in real-world settings. We will additionally crowdsource text explanations of selected sensor data points to lay a foundation for creating explainable AI/ML models.